Research Education Core

RESEARCH EDUCATION CORE ABSTRACT:
The CDU/UCLA Cancer Center Partnership's Research Education Core is central component to provide and
facilitate research educational experiences for undergraduate, graduate, medical, post-doctoral, medical
residents, clinical fellows, and early stage investigators (ESIs) to conduct translational cancer health disparities
research. In addition, this Research Education Core will continue to play a critical role in providing research
instruction to community partners in partnership with our community outreach core and health service
providers that include: community oncologists, primary care physicians and internists engaged in our Clinical
Resource Service Core. The Research Education Core will serve as portals to the other cores to enhance
cancer education, care, treatment and prevention. The Research Education Core will provde interactive and
integrated approaches for interdisciplinary and transdisciplinary programs and activities for reducing cancer
health disparities. The Core will provide four unique research experience programs: 1) a short-term 8-12 week
summer intensive research experience for undergraduate-level students in basic, clinical, or community-based
science, 2) research internships for graduate and medical students and for post-doctoral and ESIs, 3) long-
term research experiences for post-doctoral and ESIs, and 4) a community/academic research experience for
community faculty. Student scholars will be placed either at CDU or UCLA with mentors who have experience
in cancer health disparities and the student's research interest. The mentor will guide them on a hypothesis-
driven project. In addition to hands-on experience, scholars are required to participate in both scientific and
career-development seminars and workshops, research-in-progress presentations, professional presentations,
manuscript development, and grant proposal development (for graduate to ESIs). The Core has developed an
Internal Mentoring Committee composed of CDU and UCLA PIs and IAC members to review the individualized
outcomes of scholars, particularly ESIs. Evaluation and Tracking outcomes will be regularly reported and
discussed as part of the Planning and Evaluation Core activities. The overarching goal is to develop a diverse
cadre of scholars, through hands-on research experiences, into tomorrow's leaders who address will the
social, community-based, and biomedical challenges which contribute to cancer disparities.